Clinical Trial Management Support Services for ACTIV-2

Comprehensive and Rapid Response for NIAID Research Program (CARRRP): Provide the capacity and capability for a broad range of services necessary to support and conduct biomedical research in support of the NIAID mission and the management of activities specified under the Statement of Work and associated Task Orders. The purpose of this task order is to acquire comprehensive/full clinical trial management support services to the ongoing Accelerating COVID-19 Therapeutic Interventions and Vaccines (ACTIV-2) clinical trial. The objective of ACTIV-2 is to evaluate the safety and efficacy of investigational agents for the treatment of symptomatic non-hospitalized adults with COVID-19.